UIC/AJCU Training Program in Advanced Research Methods and Translational Science

Unlike many parts of the world where HIV rates are decreasing, Indonesia is experiencing an accelerating
AIDS epidemic that affects multiple vulnerable populations across a geographic span of approximately 18,000
inhabited islands. Research and research training is desperately needed to identify and test the best policies
and methods to reverse this trend. To help address this challenge, we propose to develop and implement the
“UIC/AJCU Training Program in Advanced Research Methods and Translational Science.” The program will
entail a collaborative effort between Atma Jaya Catholic University (AJCU) in Jakarta and the School of Public
Health, University of Illinois at Chicago. The program is designed to build AIDS research capacity at AJCU,
train a cadre of highly prepared Indonesian investigators to conduct innovative HIV/AIDS research using
advanced research methods and translational science, and contribute to AJCU's further development toward
becoming a Center of Research Excellence for Indonesia. Its underlying goal is to train a next generation of
HIV research investigators who can provide the innovative research needed to guide the country's policies and
programming in successfully addressing HIV. The program will meet 3 aims: (1) To train a cadre of highly
prepared Indonesian Investigators with the research skills needed to conduct innovative research that will
advise HIV social policy, intervention programming, and social/medical services; (2) To further build the
institutional HIV research capacity at AJCU and its AIDS Research Center (ARC); and (3) To contribute
through research training to AJCU's development toward becoming a Center of Excellence in HIV research
and research training for Indonesia. A mix of AIDS research training and research opportunities will be offered
that is designed to produce a next generation of Indonesian HIV/AIDS research investigators. Over the five-
year period, we will recruit and train in HIV research: 2 doctoral students in public health who will undertake
and complete all requirements for a PhD, 3 post-docs, 2 Informatics Certificate Program trainees, and 4 short-
term (3-4 month) trainees. All program trainees will be required to select an area of methodological
competence for which they will be required to develop or strengthen their research skills. They also will be
required to conduct their studies in Indonesia. Program-sponsored workshops in advanced research methods
and translational science held at both universities and also a lecture series at AJCU will inform and/or update
faculty/research investigators' and students' methodological skills. Seven program strategies will build AIDS
research capacity at AJCU and also enhance its development in becoming a Center of Excellence in HIV
research and training for the archipelago. The program meets the NIH-identified overarching priority of
providing the workforce research training required to conduct High Priority HIV/AIDS or HIV/AIDS-related
research. The long-term benefits of the program lie in its impact on improving HIV prevention, treatment, care,
and services for Indonesia.

Public health relevance
PROJECT NARRATIVE The “UIC/AJCU Training Program in Advanced Research Methods and Translational Science” is designed to build AIDS research capacity at Atma Jaya Catholic University (AJCU) in Jakarta, train a cadre of highly prepared Indonesian investigators to conduct innovative HIV/AIDS research using advanced research methods and translational science, and contribute to AJCU's further development as a Center of Research Excellence for Indonesia. The program meets the NIH-identified overarching priority of providing the workforce research training required to conduct High Priority HIV/AIDS or HIV/AIDS-related research. In doing so, its focus on advanced research methods and translational science fits the needs of AJCU and its AIDS Research Center to build institutional and investigator capacity in using advanced methodological tools to address the country's need for innovative research to guide its HIV/AIDS programming and social policy and the long-term benefits of the program lie in its impact on improving HIV prevention, treatment, and services for Indonesia.